Chimeric Antigen Receptor T Cell Design Through Living Cell Systems Biology

Project Summary
Chimeric antigen receptor (CAR) T cells represent an exciting technology for targeting drug-resistant cancers.
These cells have been developed to effectively target hematological malignancies, however have yet to find
clinical success against solid tumors, which account for the majority of cancer mortality. Solid tumors have
myriad immunosuppressive mechanisms that prevent effective CAR T cell therapies, and new methods are
needed to both elucidate these mechanisms as well as direct the engineering of these cells towards targeting
solid tumors. This proposal will take an integrated bioinformatic approach to identifying adjuvant targets to
enhance CAR T cell therapy at the site of a solid tumor or early metastatic site. Stromal and immune cells will
be sequenced at the single cell level at these sites and compared to efficacy of CAR T cell therapy. These
sequencing results will guide live cell imaging experiments, in which key transcription factors and effector
proteins will be dynamically imaged in CAR T cells in culture as they recognize and target antigen-producing
cells. Computational integration of these disparate datasets will result in adjuvant targets that will be built into
the CAR design. These new constructs will be validated both in vitro and in vivo and will provide the basis for
more advanced clinically available CAR T cell therapies.

Public health relevance
Project Narrative Chimeric antigen receptor (CAR) T cells are an emerging technology to target untreatable cancers, however have found limited success against solid tumors. This proposal will apply a new integrated bioinformatic approach combining live cell microscopy with single cell sequencing to identify adjuvant targets that can be used to enhance the CAR design and more efficiently target solid cancers. These experiments will both extend the current technology of CAR T cells and provide a foundation for more effective clinical application of these cells.